Gut-brain axis in Parkinson's disease

Project Summary
Recent studies have shown that idiopathic Parkinson’s disease (PD), the second most common
neurodegenerative disorder in the US, may originate in the gastrointestinal (GI) tract. From there it spreads via
the vagus nerve to the brainstem and, subsequently, to the dopaminergic neurons of the substantia nigra pars
compacta (SNpc). Indeed, GI symptoms such as gastroparesis and constipation are prodromal to the onset of
PD. Recently, we discovered a nigro-vagal pathway that connects the SNpc to neurons of the dorsal motor
nucleus of the vagus (DMV) and, upon SNpc stimulation, increases colonic motility. The nigro-vagal pathway is
impaired in an experimental model of PD such that SNpc stimulation increases motility to a lesser extent. We
have also generated a novel rodent model of environmental Parkinsonism, in which oral gavage of rats with
subthreshold doses of the herbicide, paraquat (P), in combination with lectins (L), a sugar binding protein found
commonly in the human diet, induces levodopa-responsive Parkinsonism. Such P+L treatment also induces
generation of pathological α-synuclein in the GI tract, as well as in the DMV and SNpc, with significant
degeneration (~50%) of dopaminergic SNpc neurons. Our preliminary data indicate that P+L treatment also
slowed gastro-cecal transit, attenuated the colonic response to excitation of the SNpc and altered the colonic
response to brainstem dopamine administration. At the same time, DMV neurons become hyperactive to
compensate for the decreased colonic motility.
Based on our preliminary studies, that demonstrate that chemogenetic blockade of the nigro-vagal
pathway prevents the development of PD, we propose the following novel hypothesis: “α-synucleinopathy-
associated GI hypomotility induces maladaptive plasticity in the nigro-vagal pathway, favoring the progression
of PD”. We further hypothesize that correction of this maladaptive neuroplasticity will forestall parkinsonism. To
investigate this novel hypothesis, we will use a combination of in vivo chemogenetic and electrophysiological,
anatomical and behavioral approaches in rodents to investigate the role of the neural pathways affected in
parkinsonian-related GI dysfunctions and in the etiology of PD.

Public health relevance
Project Narrative Increasing evidence indicates that, in a group of patients, Parkinson’s Disease (PD) may start in the gut and spread to the central nervous system via the vagus nerve. Indeed, gastrointestinal (GI) symptoms such as gastroparesis and constipation are prodromal to the onset of PD. We have discovered recently a nigro-vagal pathway that modulates colonic motility, and is impaired in an experimental model of PD. Based on our preliminary data, the present proposal aims to investigate the hypothesis that the GI hypomotility observed in PD induces a maladaptive plasticity in the nigro- vagal pathway that favors the progression of PD which, if corrected with therapeutic interventions, will slow down the progression of PD. Results from these studies will provide important translational information that will be used to target vulnerable patients and delay/ameliorate the progression of PD.